Community Engagement Core

ABSTRACT
This proposal for the Community Engagement Core (CEC) for the Pacific Center for Genome
Research (PCGR) has a long-term goal to ensure the Center’s consideration of equity and
ethics in the examination of genetic and other risk factors across the underserved and ethnic
minority groups including Native Hawaiians (NHs), Africans, Latinos, Europeans, and Asians,
served by this proposal. Additionally, the CEC will develop resources to support genetic
education and training for students, medical providers, and the broader community, including
the medically underserved communities identified for investigation. We will work closely with our
Genomic Workforce Development Core and the Administrative Core to build a repository of
resources for use in various formats to support the Center’s training and educational activities.
Additionally, we will hold annual workshops and seminars to build awareness of the implications
of genomic research in partnership with the community-based organizations working with these
underserved groups. The first aim of the CEC is to Provide clinical and community stakeholder
input and oversight for Project 1 objectives to use data from the Population Architecture using
the Genomics and Epidemiology Consortium, the Multi-Ethnic Study of Atherosclerosis, the
Genetic Epidemiology Network of Arteriopathy, INTERVAL, Atherosclerosis Risk in
Communities, UK Biobank, and Framingham Heart Study to develop genetic prediction models
to identify causally relevant biomarkers for risks of multiple diseases across African, Latino,
Asian, European, and NH groups and understand marker-risk factor interaction effects on
disease risks. The second aim is to provide clinical and community stakeholder input and
oversight for Project 2 objectives to characterize the genomic landscape, perform epigenomic
profiling and identify genomic risk factors for lung cancer in NHs by comparing them with the
genomics and epigenomics data from other ethnic groups. The final aim of the CEC is to
support student, stakeholder, and community education and awareness of the U54 PCGR. To
achieve these aims, the CEC will convene Community Advisory Boards to support the
promotion and education about the two U54 PCGR projects among physicians, content experts,
and community stakeholders. The CEC will also develop and implement a regular series of
community seminars and workshops to disseminate U54 PCGR and external genome research
leaders’ scientific findings and identify strategies for implementing risk identification methods in
clinical settings. As a result, the CEC will contribute y to the success of the U54 PCGR projects
and provide an optimal foundation for future genomic research at the University of Hawaii.

Public health relevance
NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT The Community Engagement Core (CEC) will provide the oversight needed to ensure the U54 Pacific Center for Genome Research (PCGR)’s consideration of equity and ethics in the examination of genetic and other risk factors across the underserved and ethnic minority groups, including Native Hawaiians (NHs), Africans, Latinos, Asians, and Europeans served by this research. The CEC will broadly engage these populations and their providers to increase their awareness of genetic and omic risks for disease and obtain their input on our research. The CEC activities will support the dissemination of findings from the two PCGR projects includingProject 1, to better characterize roles of genetically predicted DNA methylation, gene expression, protein expression, and metabolite levels in the blood tissue and known non-genetic risk factors in influencing risks of multiple diseases across NHs, Africans, Latinos, Asians, and Europeans, and Project 2, to characterize genomic risk factors of lung cancer in NHs.